Water Intake and Weight Control in Older Adults

Project Summary/Abstract
The lack of practical and effective strategies to manage hunger and adhere to a weight management intervention
represents a critical barrier to the weight management field. In proof-of-concept efficacy studies, we have
demonstrated that premeal water consumption (500 ml) acutely reduced perceived hunger and meal energy
intake among middle-aged and older adults, and that premeal water consumption (500 ml, 3 times per day)
increased the amount of weight lost (i.e., 2 kg greater loss) after 12 weeks among middle-aged and older adults
with overweight or obesity. However, water consumption may be important for weight management regardless
of when it is consumed. To address this possibility, we propose a rigorously-designed randomized controlled
intervention trial in adults aged 50+ years with overweight or obesity comparing three groups with different diet
prescriptions: 1) pre-meal water consumption (500 ml, before each main meal) with a hypocaloric diet; 2) 1500
ml water consumed throughout the day with a hypocaloric diet; 3) hypocaloric diet with no instructions regarding
water consumption. Smart water bottles will objectively assess water intake timing and volume. Urine osmolality,
urine volume, and serum osmolality will be used as objective indicators of compliance with the water intake
prescription. We will investigate changes in perceived hunger and fullness and appetite-regulating hormones as
potential mechanisms by which premeal water could improve appetite regulation. We will also investigate the
impact of water consumption and hydration on executive function capabilities, which may influence intervention
adherence. We hypothesize that weight loss at 12 weeks, and weight loss maintenance at 12 months, will be
greater in the premeal water group compared to the daily water volume and control groups. Furthermore, when
combined with a hypocaloric diet, premeal water will reduce hunger and increase fullness; these changes will
mediate adherence to the hypocaloric diet and weight loss outcomes. Although increasing water intake could be
an effective weight management strategy, no evidence-based recommendations exist for the timing of water
intake needed for this benefit. Our findings could identify a low-cost, actionable dietary strategy that could be
incorporated into clinical practice guidelines for obesity treatment, and improve adherence to a hypocaloric diet
prescription through reduced hunger, increased fullness, and improved attention and inhibitory control. This
proposal is aligned with the 2020-2030 NIH Strategic Plan for Nutrition Research (Objective 3.5) and the Dietary
Guidelines for Americans 2020-2025 due to its focus on older adults, an understudied population at increased
risk for obesity and inadequate hydration. If effective, this hydration/weight control intervention approach could
be applied to clinical populations such as adults with obesity who are prescribed increased water intake to
prevent or treat kidney stone disease or urinary tract infections, which are common in older adults.

Public health relevance
Project Narrative Greater than two-thirds of mid-life and older adults are overweight or obese, and older adults with obesity face greater risk of disability, cognitive impairment, impaired mobility, and higher medical expenses. Thus, lifestyle interventions which promote moderate, sustainable weight loss among mid-life and older adults with overweight or obesity are needed. As there are currently no evidence-based water intake recommendations for weight control, we aim to address this research gap by investigating premeal water as a low-cost dietary strategy that could be incorporated into clinical practice guidelines for obesity treatment, and improve adherence to a hypocaloric diet prescription through reduced hunger, increased fullness, and improved cognitive function.